Structural, functional, and mechanistic anlaysis of autoreactive CD8 T cells

ABSTRACT
CD8 T cells are important contributors to the pathology observed in many autoimmune diseases,
including type 1 diabetes. Despite the importance of autoreactive CD8 T cells, much fundamental knowledge
is lacking in several major areas, including i) the properties of class I MHC alleles that confer susceptibility or
resistance to disease; ii) the determinants that underlie the promiscuous antigen recognition often displayed by
autoreactive T cells; and iii) the contribution of the CD8αβ co-receptor in facilitating autoimmune processes.
These are the critical knowledge gaps that we seek to fill, and we will do so using a multidisciplinary approach
and a collection of innovative strategies, reagents, and animal models. In Aim 1, we will define the
biochemical and structural features and in vivo peptide presentation properties of human class I MHC alleles
associated with susceptibility or resistance to type 1 diabetes. These studies will focus on HLA-B*39:06,
B*39:01, and B*38:01, a closely related group of class I MHC alleles that are differentially associated with
disease. We will test the hypothesis that the differential ability of these three alleles to mediate disease is the
consequence of differential binding and presentation of certain disease-relevant beta cell peptides. Our newly
developed NOD mouse models expressing human insulin or human IGRP will be central to this aim. In Aim 2,
we will use the T cell receptors from a set of promiscuous and autoreactive CD8 T cell clones in structural and
mutagenesis studies to define the mechanisms that underlie T cell receptor cross-reactivity. Among other
approaches, we will take advantage of novel high-throughput assays that we have developed both to identify T
cell epitopes and map protein binding interfaces. In Aim 3, we will use biochemical and biophysical
approaches and in vivo models to better understand the interaction between CD8αβ and peptide-MHC.
Despite the requirement of CD8αβ for CD8 T cell selection and peripheral activation, and its potential as a
therapeutic target, crystallographic analysis of its interaction with pMHC is limited to a single structure of
murine CD8αβ with H-2Dd. Our own findings from mouse models we have recently characterized suggest that
human CD8αβ may be interacting with class I MHC in a manner not revealed by the single available structure.
While autoreactive CD8 T cells under study here are likely to exhibit some unique features due to their
necessity to escape tolerance mechanisms, much of what will be learned will be fundamental knowledge that is
generally applicable to CD8 T cell biology and that will help guide the future development of more effective
approaches to manipulate and harness the immune system in health and disease.

Public health relevance
PROJECT NARRATIVE CD8 T cells are important contributors to the pathology observed in a whole host of autoimmune diseases, including type 1 diabetes. The goal of our project is to fill critical knowledge gaps regarding the protein-protein interactions that govern the activity of autoreactive CD8 T cells. In addition to their participation in autoimmune disease processes, CD8 T cells also play critical roles in pathogen and tumor elimination. Although our efforts will be expended in the context of autoreactive CD8 T cells, much of what we will learn will be fundamental knowledge that will apply to general CD8 T cell biology. Our findings will guide the future development of more effective approaches to manipulate the immune system in health and disease.